Immune Metabolism of Peripheral Nervous Tissue Degeneration and Regeneration

Abstract:
Trauma to the adult mammalian peripheral nervous system (PNS) typically results in motor and sensory
deficits. While PNS injury induces a strong regenerative response in axotomized neurons, functional recovery
in humans is often incomplete and frequently accompanied by the development of chronic pain. PNS injury
also triggers nerve inflammation, with immune cells playing vital roles in tissue healing and functional
restoration. To better understand the immune response to sciatic nerve injury in mice, we performed a
longitudinal analysis using a combination of flow cytometry and single-cell RNA sequencing. Our analysis
revealed distinct and location-specific immune milieus at the site of injury and in the distal nerve. In addition to
tissue-resident macrophages, blood-borne monocyte-derived macrophages (MDMs) massively accumulate at
the injury site and in the distal nerve, where axons undergo Wallerian degeneration. Previous studies have
shown that immune cells regulate processes such as nerve debridement, angiogenesis, axon regeneration,
and pain. However, the specific roles, ontogeny, and functions of macrophage subpopulations remain poorly
understood. To differentiate between blood-borne MDMs and tissue-resident macrophages, we propose
experiments with transgenic mice (qMCP-/-) deficient for five monocyte chemotactic proteins. Preliminary
studies with qMCP-/- mice demonstrated absence of MDMs in the injured PNS. Pathway analysis of single cell
transcriptomes from injured sciatic nerves of wildtype mice revealed that MDMs undergo profound changes in
their energy metabolism and inflammatory state. The metabolic state of macrophages is of particular interest
because it determines their function: high glycolytic activity is a hallmark of pro-inflammatory cells, while
elevated mitochondrial oxidative phosphorylation (OXPHOS) characterizes anti-inflammatory cells. Thus,
genetic manipulations that disrupt specific metabolic pathways for ATP production offer an opportunity to
investigate the roles of specific macrophage activation states in PNS injury. Our preliminary data show that
selective disruption of glycolytic flux in MDMs impairs motor and sensory axon regeneration and function. Our
central hypothesis is that MDMs are essential for PNS repair, and that metabolic reprogramming from high
glycolytic flux to OXPHOS is critical for successful nerve fiber regeneration and the mitigation of neuropathic
pain. To test this hypothesis, we propose two Specific Aims. Aim 1: Conduct a detailed analysis of the repair
response in qMCP-/- mice, subjected to different types of PNS injuries. Aim 2: Use conditional gene ablation of
key regulators of glycolysis and nerve inflammation, to assess their impact on location-specific immune milieus
in the injured PNS, regenerative outcomes, and chronic pain. The proposed studies represent the first
systematic analysis of Mac subpopulations in the injured mammalian PNS, their ontogeny, and metabolic
plasticity. Insights gained will elucidate how impaired immune cell function impacts tissue repair, functional
recovery, and chronic pain.

Public health relevance
Project Narrative: Injury to peripheral nervous system tissue causes rapid nerve inflammation, marked by the infiltration of blood- borne immune cells. These cells differentiate into multiple macrophage subpopulations, whose roles in tissue repair remain poorly understood. A hallmark of nerve inflammation is the rapid transition in macrophage inflammatory profiles, shifting from pro-inflammatory (M1-like) to resolving (M2-like). This project aims to investigate the functional significance of these blood-borne macrophage subpopulations and their phenotype switching in nerve repair and the development of neuropathic pain.